Real-time lexical access and semantic activation during masked speech recognition in children with normal hearing and children with hearing aids

PROJECT SUMMARY/ABSTRACT
Background noise is ubiquitous in children’s everyday listening and learning environments and can be
detrimental to speech recognition. Even when maskers are not intense enough to reduce speech recognition
accuracy, children’s listening comprehension can suffer, especially among children who use hearing aids (HAs).
A possible explanation for this is that maskers may reduce children’s real-time speech processing efficiency,
thereby impacting comprehension. Specifically, maskers may cause delayed lexical access (word form
recognition) and semantic activation (word meaning recognition), causing children to struggle to keep up with
continuous speech input in complex listening environments. The proposed study will use a Visual World
Paradigm eye-tracking task to directly examine the effects of masking on real-time speech processing efficiency
in school-age children with normal hearing (NH) and children with HAs. In particular, the effects of speech-shaped
noise and two talker-speech maskers will be examined to disentangle the impacts of energetic and informational
masking on lexical access and semantic activation speed. Aim 1 examines the development of real-time lexical
access and semantic activation while listening in speech-shaped noise and two-talker speech among children
with NH. Eye-tracking data from children ages 7 to 17 will be compared to adult data to determine the
developmental trajectory of the two real-time processes (lexical access and semantic activation) in the two types
of maskers (speech-shaped noise and two-talker speech). Aim 2 will examine the effects of pediatric hearing
loss on real-time lexical access and semantic activation while listening in competing maskers by comparing these
processes in children with HAs to those of children with NH. Cognitive skills and auditory access factors will also
be examined as possible predictors of individual differences in lexical access and semantic activation during
masked speech recognition. The knowledge gained from this study will be crucial for enacting guidelines for
classroom acoustics that promote effective listening and learning environments for all children, as well as for
improving understanding of factors that contribute to children’s natural communication in complex everyday
contexts. Furthermore, findings will contribute to the development of more targeted interventions to improve
listening and language comprehension for children with HAs. This study will address the NIDCD mission to
support research in the normal and disordered processes of hearing and language.

Public health relevance
PROJECT NARRATIVE Children with and without hearing loss can struggle to understand speech in noisy environments, which may be due in part to negative effects of auditory maskers on children’s speech processing efficiency. The proposed project will characterize the development of children’s real-time processing efficiency while listening to masked speech, as well as compare these processes in children with normal hearing and children with hearing aids. Findings will inform recommendations for classroom noise management, improve our understanding of the mechanisms underlying listening and spoken language difficulties in children with hearing aids, and support the development of clinical interventions supporting complex listening skills in children with hearing loss.